Biomedical Imaging for Clinician Scientists

Project Summary/Abstract
This is the third renewal application of a structured intensive one-year training program in Biomedical
Imaging based in the Department of Radiology and Biomedical Imaging at UCSF. Over the last 14
years the program has been very successful in training leaders in Academic Radiology with the new
chair being one of the Department’s first group of T32 fellows. The T32 program will be open to
radiology residents who are in or have completed residency training. The primary long-term objective of
this program is to train Academic Radiologists who will become leaders in Biomedical Imaging, promote
interdisciplinary research and thus help address the current lack of such clinician scientists. More
specifically, the program will recruit candidates who will be mentored by a designated team of
experienced researchers including clinical radiologists, basic scientists, and clinicians. Each trainee will
be affiliated with one of the existing sections and research groups within the Department of Radiology
and Biomedical Imaging, and collaborate with researchers from the departmental laboratories and
clinicians from other departments in multidisciplinary research projects. UCSF’s Department of
Radiology and Biomedical Imaging is ideally positioned to provide such a training program, given the
large research program and the high percentage of researchers within the Department. There is a long
history of interdisciplinary collaboration at UCSF and the depth and diversity of the clinical and research
work within the Department of Radiology and Biomedical Imaging provides an optimal environment for
the T32 trainees. The T32 trainees will be based within the new Life Sciences Mission Bay and China
Basin campuses of UCSF, which offer unique resources for collaborative research. These new
resources will further increase the ability of the Department of Radiology and Biomedical Imaging to
attract researchers and continue the long tradition of ground breaking, cutting edge Biomedical Imaging
Research at UCSF.

Public health relevance
Public Health Relevance Statement There is currently a shortage of Academic Radiologists rigorously trained in Biomedical Imaging Research; these highly skilled and trained individuals, however, are critical to advance research in imaging and image-guided therapies, which will directly impact patient care. This new generation of Academic Radiologists will be crucial to maximize the healthcare benefits that will flow from interdisciplinary translational research linking advances in the sciences of genomics, proteomics and artificial intelligence with the ongoing technological evolution in Biomedical Imaging.